The role of PTEN in epigenetic and metabolic regulation of IDH-mutant gliomas

ABSTRACT
Astrocytic tumors of the central nervous system (CNS) are intractable tumors and harbor dismal outcomes due
to a lack of targeted treatment options. More than 70% of astrocytic tumors bear mutations in the TCA cycle-
related gene, isocitrate dehydrogenase 1 (IDH1). Wildtype IDH1 catalyzes the oxidative decarboxylation of
isocitrate to generate α-Ketoglutarate (αKG), while mutated IDH1 (IDH1m) metabolizes αKG into the
oncometabolite D-2-hydroxyglutarate (D2HG). Several epigenetic dioxygenases including histone and DNA
demethylases require αKG to demethylate histone residues and DNA CpG islands. D2HG competitively
inhibits these enzymes due to its structural similarity to αKG. This results in an increase in histone and DNA
methylation referred to as the glioma-CpG island methylation phenotype (G-CIMP). However, DNA methylation
G-CIMP levels are not uniform in IDH1m astrocytomas. IDH1m astrocytomas with low versus high levels of G-
CIMP bear a particularly grim prognosis. My preliminary data identifies PTEN loss of heterozygosity (LOH) as
the top genetic alteration in G-CIMP low versus G-CIMP high tumors. Moreover, PTEN LOH independently
related with a poor prognosis. However, it remains unknown how PTEN LOH drives tumorigenicity in IDH1m
astrocytomas. Our premise is based on the observation that PTEN is a critical tumor suppressor. In other
cancers, PTEN LOH activates PI3-kinase (PI3K)/AKT-mTOR signaling to drive tumor growth through various
mechanisms including metabolic reprogramming. My preliminary data demonstrates increased cell proliferation
in IDH1m astrocytic cell lines with partial PTEN knockdown (KD) accompanied by a reduction in D2HG levels.
Based on my premise and preliminary data, I hypothesize that PTEN LOH activates PI3K/AKT-mTOR signaling
to metabolically reprogram IDH1m astrocytomas to reduce D2HG levels and thereby mediate lowered DNA
methylation and G-CIMP levels. Subsequently, targeting PI3K/AKT-mTOR signaling represents a promising
candidate for therapeutic development. To test this hypothesis, I propose two specific aims. Aim 1 will map
alterations in metabolic pathways that generate D2HG in human and murine-derived IDH1m astrocytomas with
or without PTEN reduction using a novel in-utero electroporation (IUE) Pten +/- IDH1m model. In parallel, I will
assess corresponding genome wide epigenetic alterations including DNA methylation using next generation
sequencing-based epigenetic assays in relation to changes in gene expression. Aim 2 will determine if
targeting PTEN LOH-driven PI3K/AKT-mTOR activation is therapeutic in vitro and proof-of-principle in animal
models. Together, my work will address a critical gap in our knowledge by defining how PTEN LOH drives a
subset of aggressive IDH1m astrocytomas via metabolic reprograming and lay the groundwork for developing
targeted and effective therapies for malignant IDH1m astrocytomas.

Public health relevance
PROJECT NARRATIVE Astrocytomas are a deadly and intractable form of brain cancer that frequently bear mutations in the TCA cycle-related gene, isocitrate dehydrogenase 1 (IDH1m). A subset of these tumors bears grim prognoses and demonstrate lowered levels of DNA methylation. This study aims to (1) determine how epigenetic and metabolic processes are altered in IDH1m astrocytomas and (2) develop targeted strategies for more efficient treatment of these tumors.